Strategies to Improve Communication Structure and Quality in Low-resource Childhood Cancer Hospitals

PROJECT SUMMARY/ABSTRACT
Children with cancer in low-resource settings face a survival rate of only 20%. Clinical
deterioration, defined as the worsening of patient status that requires clinical teams to recognize
and respond in a coordinated fashion, remain a major cause of childhood cancer mortality
globally. Interdisciplinary communication is essential to high-quality cancer care, especially
during high-acuity events such as clinical deterioration. Despite knowledge that high quality
interdisciplinary communication improves patient care and outcomes, we lack an understanding
of specific modifiable determinants of communication quality and appropriate, usable, and
measurable communication interventions. This is particularly true in low-resource settings. We
have previously developed a valid, reliable, multilingual measure of communication quality
during clinical deterioration and have conceptualized that communication structure and quality
interact to directly impact the quality of childhood cancer care. The goal of this proposal is to
develop and test a bundled multilevel intervention that responds to modifiable determinants of
interdisciplinary communication quality and structural communication patterns in low-resource
pediatric oncology hospitals to improve communication and care delivery. To accomplish this
goal, we will engage clinicians and hospitals in low-resource settings. In Aim 1 we will identify
the relationship between communication structure and quality in the care of children with
cancer. We will conduct a cross-sectional social network analysis from 10 high-quality
communication and 10 low-quality communication hospitals as determined by previous work. In Aim
2, we will develop a multilevel intervention to improve communication quality in low-resource
hospitals. We will conduct a sequential mixed methods study using quantitative data from Aim 1
supplemented by qualitative interviews with clinicians. Following this, we will engage a global panel
of experts in communication and clinical care to conduct implementation mapping, which will develop
and prioritize an intervention to address common communication challenges. In Aim 3 we will
conduct a cluster randomized control trial to test the feasibility and preliminary effectiveness of
this multilevel intervention to improve communication quality in low-resource hospitals. We will
test the identified intervention bundle at 8 low-resource hospitals. Our primary outcome will be the
change in communication quality score, and we will also assess the feasibility, acceptability, and
appropriateness of the intervention among frontline clinicians. When complete, this work will
improve interdisciplinary communication and clinical outcomes for children with cancer in
hospitals of all resource levels, thus advancing health equity globally.

Public health relevance
PROJECT NARRATIVE Strategies to improve interdisciplinary communication that are responsive to needs in low resource settings are needed to improve childhood cancer globally. This project identifies determinants of communication in low resource settings prior to co-developing and testing interventions with staff from these impacted settings. When completed, this study will produce evidence informed, multilevel interventions to improve team communication during patient deterioration, advancing the science of multidisciplinary communication during cancer care, and ultimately improving survival for children with cancer globally.